Investigating mediodorsal thalamus representations underlying human cognitive flexibility

PROJECT SUMMARY
The human brain's ability to learn and execute behaviors tailored to environmental contingencies is crucial for
adaptive cognition. Central to this capacity are neural representations of context, which organize the associations
between sensory features and behavior utility. Despite their significance, the neural mechanisms underlying the
encoding and updating of context representations remain poorly understood. This gap in knowledge is
particularly relevant for understanding cognitive deficits in psychiatric disorders such as schizophrenia and
ADHD. Our research proposes to test the hypothesis that the human mediodorsal (MD) thalamus is critical for
encoding, updating, and generalizing context representations. This hypothesis is grounded in empirical and
theoretical contributions from our team, suggesting the MD thalamus's essential role in context-guided cognitive
control and flexibility. Our previous studies have shown that damage to the MD thalamus impairs task switching
and working memory in humans, consistent with findings from non-human animal models. Additionally, single-
unit recordings in animals reveal that MD neurons rapidly encode task context, a process dependent on the
convergence of prefrontal afferents. Preliminary fMRI data from our labs indicate that the human MD thalamus
tracks task context and its updates following switches. However, a critical gap exists in interpreting these results
due to the lack of quantitative models and advanced neuroimaging approaches to delineate the specific
representations and computations carried out by the human MD. To address this gap, we will use a
computational cognitive neuroscience approach, integrating computational models with high-resolution 7T MRI
and advanced neuroimaging analyses. Our research has three specific Aims. In Aim 1, we will ask whether the
MD thalamus encodes context representations that organizes how working memory guides task selection. In
Aim 2, we will ask whether the MD encodes context prediction errors that switch prefrontal task representations
flexibly. In Aim 3, we will ask whether MD context representations enable generalization to novel stimulus-
response contingencies during decision-making. For all aims, we will develop computational models that specify
both cognitive processes and neural implementations to predict behavior and guide neuroimaging data analyses.
This collaborative effort between the MPIs aims to establish a new conceptual and empirical framework for
understanding thalamic computation in humans, with significant implications for theories of cognitive control,
adaptive human behavior, and cognitive dysfunction.

Public health relevance
PROJECT NARATIVE This research is important for public health because it aims to understand how the human mediodorsal thalamus enables cognitive flexibility. Disruptions in mediodorsal function is observed in schizophrenia and ADHD, which may lead to impulsivity, cognitive rigidity, and perseveration. Our study aligns with the NIH mission by potentially improving the diagnosis and treatment of these disorders, leading to better outcomes for affected individuals.